Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT: ABSTRACT
The Georgetown Lombardi Comprehensive Cancer Center (LCCC) Consortium is committed to reducing the
cancer burden and improving cancer equity through close collaboration with communities in its catchment area.
To achieve this goal, the LCCC Community Outreach & Engagement (COE) office supports multiple cancer-
related activities across the cancer care continuum, including needs assessment and dissemination, community
engagement, prevention and control, screening and early detection, community education, facilitation of
catchment-area research, and influence in cancer-related policy changes. The LCCC catchment area represents
a geographically and socio-demographically diverse population of approximately 6.5 million people comprising
Blacks (25%), Hispanic/Latine (23%) and a rapidly increasing Asian population (13%). This area includes DC
and surrounding counties in Maryland and Virginia; and Bergen County and its surrounding counties (Passaic
and Hudson) in Northern New Jersey (NJ) with diverse cancer and cancer risk burdens. Led by Lucile Adams-
Campbell, PhD, Associate Director for Minority Health and COE, the COE office includes a diverse and bilingual
staff representative of catchment area communities. The leadership team includes Chiranjeev Dash, PhD, MBBS
MPH and Lisa Carter-Bawa, PhD, APRN as co-Directors of COE in DC and NJ, respectively. COE activities are
guided by the LCCC strategic plan, supported by input from external stakeholders and community members
comprising the Community Advisory Council, and are conducted in close collaboration with LCCC Research
Programs, CRTEC and DEI teams. The Specific Aims of COE are to: (1) identify and monitor the cancer burden
and risk factors within the LCCC catchment area; (2) conduct cancer-focused outreach and engagement to
disseminate and implement evidence-based research and policy in the LCCC catchment area and beyond; and
3) facilitate catchment area-relevant research with special emphasis on vulnerable and underserved populations.
COE activities across aims are focused on catchment area priorities of reducing breast, lung, gastrointestinal,
hematologic, and prostate cancer disparities, increasing cancer screening, diagnosis, and treatment among
populations with social determinant barriers, facilitating community-engaged translational research on smoking
cessation and genetic counseling and testing, increasing minority accruals to therapeutic and non-therapeutic
clinical trials, and promoting healthy survivorship across the lifespan.